The role of subjective values and dopamine availability in incentive-based motor learning

PROJECT SUMMARY/ABSTRACT
Advances in virtual and augmented reality, wearable technology, and commercialized gaming
systems have led to the increased use of gamified physical rehabilitation interventions. These
interventions rely on a structure of incentives (i.e., providing or removing points for good or poor
performance) to drive behavioral changes and are thought to increase motivation and
engagement over non-gamified interventions. Whether gamified interventions improve
rehabilitation outcomes beyond standard care is unclear, however, especially for people with
neurologic disorders like Parkinson’s disease (PD), where the processing of incentives may be
impaired. The current understanding of how the motor system learns in response to incentive
structures is rather poor. In particular, little work to date has addressed how subjective value, a
fundamental principle of behavioral economics known to govern incentive-based motivation and
decision-making, shapes motor learning in health and disease. This critical gap prevents us from
optimally applying incentive structures to maximize outcomes during rehabilitation interventions
across patient populations. Therefore, the overall objective of this work is to test a novel
theoretical framework for how incentives drive changes in motor learning. The central hypothesis
is that subjective perceptions of incentives (i.e., subjective values) drive incentive-based motor
learning. This theory implies that incentive structures could be customized for individuals or for
patient populations to maximize motivation and learning from gamified rehabilitation interventions.
To test this theory, an established method from behavioral economics will be used to measure
individual subjective values, and a reaching task will be used to test the magnitude of incentive-
based motor learning. Aim 1 will determine the extent to which subjective value dictates motor
learning in neurotypical individuals. Aim 2 will determine how subjective values are impacted by
PD, which is characterized by reduced dopamine production, a neurotransmitter that has been
linked to incentive processing. Overall, the proposed research will deepen our understanding of
how people learn new behaviors in response to incentives. The research and training proposed
in this fellowship will be completed in a strong research environment under the guidance of an
exceptional team of experienced mentors. The applicant will develop skills related to the design,
execution and analysis of motor learning and translational rehabilitation research, all of which
have been specifically selected to achieve his long-term career goal of improving neurologic
rehabilitation practice.

Public health relevance
PROJECT NARRATIVE Gamified interventions involving incentive structures (e.g., winning or losing points based on performance) are becoming more common in rehabilitation clinics as a way of motivating and engaging patients. However, there is mixed evidence on whether gamified interventions actually improve motor function in people with neurologic disorders like stroke and Parkinson’s disease, likely stemming from a poor understanding of how the motor system learns in response to these types of incentives. This project tests a novel theoretical framework that will inform how incentives can be used to maximize motor rehabilitation outcomes in health and disease.